High-throughput systematic characterization of regulatory element function

Project Summary This application is an administrative supplement request for 5UM1HG009436. The ENCODE project has produced high-resolution, high-quality maps of components of the `regulome' in a set of tissues and cell lines, identifying a collection of putative regulatory elements. Our proposal aims to generate and release data that test the functional relevance of these putative elements with high-throughput, pooled CRISPR screens, as well as a number of other methods that are aimed to understand the relationship between transcription factor levels, global accessibility at regulatory elements, an the effects on gene expression.

Public health relevance
Project Narrative This administrative supplement request will allow the generation and submission of large data sets that test putative functional elements with powerful, high-throughput gene editing and perturbation technologies coupled with high-throughput genome wide characterization of chromatin structure and gene expression, providing a validation as to the regulatory potential of these identified genomic elements.